Cancer misinformation on social media and its correction

Project Summary
The overarching goal of this study is to measure the prevalence of cancer misinformation on social media and
understand the mechanisms that underlies its spread. Belief in misinformation can have serious ramifications,
particularly when the misinformation is regarding life threatening conditions such as cancer. We currently lack
answers to even basic questions regarding cancer misinformation online. For example, how much cancer
misinformation is there on social media? How do people make assessments of trust and source credibility?
How well do people update their beliefs when cancer misinformation is corrected? What are the psychological
mechanisms of this belief updating? This Pathway to Independence Award (K99/R00) application by Dr.
Briony Swire-Thompson intends to fill this knowledge gap by building on her prior research regarding
misinformation prevalence on social media, source credibility, and the correction of misinformation. The
proposed research will be complemented by focused training on three areas, (1) increasing Dr. Swire-
Thompson’s knowledge of cancer and cancer misconceptions (2) furthering her social media data skills, and (3)
fostering professional development to facilitate the transition into an independent research position. These
training goals will be supervised by an interdisciplinary mentoring team. This team will be led by Dr. Lazer, a
University Distinguished Professor of Computer Sciences at Northeastern University’s Network Science
Institute. The co-mentors will be Dr. Viswanath, a cancer communications expert and Lee Kum Kee Professor
of Health Communication at the Harvard T. H. Chan School of Public Health, and Dr. Johnson, an oncologist
and Assistant Professor at the University of Utah’s School of Medicine. This training will aid Dr. Swire-
Thompson to answer three specific research aims. First, the prevalence of cancer misinformation on social
media will be investigated. In the K99 phase, she will focus on Twitter to investigate who is more likely to be
exposed to and share cancer-related misinformation. In the R00 phase this will be extended to Facebook,
where we invite a representative sample of individuals to donate their social media data and respond to surveys
regarding their relationship with cancer, and why they share information. The second specific aim is to
investigate how people make judgements of source credibility, and the extent that credibility is reduced when
cancer sources are disreputable (such as spreading misinformation or having a lack of expertise). The third
specific aim is to understand the cognitive mechanisms behind updating belief in cancer misinformation. This
will be conducted by exploring whether cancer-related misinformation is more difficult to correct than non-
cancer related misinformation, and if so, why? This will be tested in both a general population and a population
whose close relatives have cancer. In sum, this 5-year research and training plan will allow Dr. Swire-
Thompson to establish an independent research program dedicated to understanding cancer misinformation
on social media and its correction.

Public health relevance
Project Narrative The goal of the current project is to measure the prevalence of cancer misinformation on social media and understand the mechanisms that underlies its spread. Specifically, it aims to (1) characterize the prevalence of cancer misinformation on social media, namely Twitter and Facebook, (2) investigate how people make judgements of source credibility with regards to disreputable cancer sources, and (3) understand the cognitive mechanisms behind updating belief in cancer misinformation.